Regulation and function of HOX genes in Ewing sarcoma pathogenesis

PROJECT SUMMARY
Hijacking of normal developmental programs is a common mechanism of tumorigenesis and epigenetic
deregulation of developmental transcription programs is central to the genesis of most, if not all, pediatric
cancers. Ewing sarcomas, aggressive bone and soft tissue tumors that predominately arise in adolescence,
continue to be associated with high rates of mortality and novel approaches to therapy are needed. Ewing
sarcomas are characterized by the presence of pathognomonic driver fusion oncogenes, most commonly
EWS/FLI1, and their likely cellular origin is mesenchymal stem/progenitor cells (MSC). EWS/FLI1 initiates
tumorigenesis by inducing widespread disruption of transcriptional regulation as a consequence of altered
recruitment of chromatin remodelers to target gene enhancers and promoters. We have reported that posterior
HOXD genes, in particular HOXD13, are aberrantly over-expressed by Ewing sarcoma and that posterior
HOXD genes contribute to maintenance of the tumorigenic phenotype. Our preliminary studies suggest that
EWS/FLI1 can induce expression of HOXD13, in a cell context dependent fashion, and that this activation is
mediated by aberrant activation of developmental enhancers that are otherwise active in only very discrete
spatiotemporal developmental windows. In addition, chromatin immunoprecipitation (ChIP) studies have
demonstrated that in EWS/FLI1+ cells the HOXD13 promoter is preferentially enriched with the MLL-
dependent activating histone modification H3K4me3 and bound by both MLL and menin proteins. Significantly,
exposure of Ewing sarcoma cells to novel small molecule inhibitors of MLL:menin interaction, that are currently
in preclinical development for MLL-fusion positive leukemias, leads to a dramatic loss tumorigenicity and
concomitant loss posterior HOXD gene expression. Thus, these studies demonstrate that that, like MLL-fusion
positive leukemias, maintenance of the oncogenic phenotype of Ewing sarcoma is critically dependent on
MLL:menin-dependent activation of developmental HOX genes. In this proposal, we will test the hypothesis
that HOXD13 functions an obligate cooperative oncogene in Ewing sarcoma and that dependency on its
continued expression presents a previously unrecognized tumor-specific vulnerability that can be
therapeutically exploited. In Aim 1 will use innovative Bru-seq technologies and functional validation studies to
define the downstream transcriptional targets of HOXD13 that promote tumorigenicity. In Aim 2 we will use
targeted ChIP assays and chromatin conformation studies to determine how EWS/FLI1 leads to epigenetic
activation of HOXD13. In Aim 3 we will test the therapeutic potential of MI-503, a small molecule inhibitor of
MLL:menin protein:protein interaction, in in vivo tumor models. These studies will together elucidate the
contribution of HOXD13 to Ewing sarcoma pathogenesis and test the potential of a new class of epigenetic
modifying agents for Ewing sarcoma-targeted therapies.

Public health relevance
Project Narrative Genes that are essential for normal embryonic and post-natal development of organs and tissues are frequently hijacked in disease, in particular in the context of pediatric cancers. We have discovered that HOXD13, a gene that is normally expressed only in early limb development, is aberrantly activated in Ewing sarcoma, a bone and soft tissue tumor that peaks in adolescence. In this proposal we investigate the mechanistic basis of HOXD13 activation in Ewing sarcoma and define the downstream targets of HOXD13 that contribute to tumor growth and progression. In addition, we will test whether targeting HOXD13 using epigenetic drug therapy presents a novel therapeutic opportunity for Ewing sarcoma patients.